Preventing Opioid Exposure Training (POET) for First Responders

PROJECT SUMMARY/ABSTRACT In this competitive revision Phase I SBIR, Gryphon Scientific proposes to expand the scope of the ongoing project to support the urgent need to develop and deploy training for first responder populations at risk of exposure to the novel coronavirus (COVID-19). The ongoing Phase I SBIR project focuses on training first responders (including law enforcement, fire, and EMS personnel) to recognize and manage the risks of occupational opioid exposures. The training video format was chosen following formative research interviews with first responders, which revealed a clear preference for training that could be administered to groups during short stand-up briefings. Currently, training content specifically includes topics such as routes of opioid exposure, PPE, situational awareness, and recognizing and responding to exposure events. In this supplemental application, Gryphon proposes to expand the scope of the study by developing similar training videos on topics related to the transmission of respiratory diseases, primarily focused on COVID-19. Specific topics may include pathogen fundamentals, transmission routes, and recommended measures to manage risk, including distancing measures when feasible, and the selection of appropriate personal protective equipment (PPE) for various situations, including those where shortages preclude the use of recommended PPE. Recognizing the urgent need to deploy this training to the first responder community, videos would be published as free and ad-supported on YouTube immediately following their development. These videos could be used as standalone just-in-time training, as refreshers throughout the pandemic, or as multimedia supplements to longer, more comprehensive e-learning courses to reinforce key principals using a dynamic and engaging medium. Even before the pandemic, educators and researchers called for enhanced pathogen literacy in the general public as an essential component of pandemic preparedness. This study proposes to collect valuable data on learners’ understanding of pathogen safety fundamentals and the potential efficacy of remote educational approaches to enhance microbiological literacy. Usability testing and knowledge retention (both immediately after training and three months later) research will be integrated into the base Phase I study by testing these videos at the same time as those on opioid exposures. The initial products developed in this study may directly improve microbiological literacy among at-risk populations, and these early studies may help to inform future training interventions.

Public health relevance
PROJECT NARRATIVE Based on the formative research findings in our active grant, we are developing a series of training videos to teach police officers and other first responders how to recognize and manage occupational opioid exposure risks. Building on these findings, we plan to address the current need for first responders to receive additional training on the transmission of respiratory diseases (particularly COVID-19) through the development of short training videos on topics such as pathogen fundamentals and transmission routes, and recommended measures to manage risk, including distancing measures when feasible and the selection of appropriate personal protective equipment (PPE) for various situations. The public interest in maintaining first responder safety will be well served by these expansions to the scope of the existing work.